Capacity Building for the Diagnosis and Treatment of Neuromyelitis Optica using Point of Care Aquaporin-4 Antibody Testing

Neuromyelitis optica (NMO) is an autoantibody-mediated disease of the central nervous system, predominantly
affecting women and disproportionately people of African descent. The diagnosis of NMO is contingent upon the
accurate detection of the aquaporin-4 (AQP4) antibody, the disease's sensitive and specific biomarker. The
availability, accessibility, and affordability of the AQP4 antibody test is low in low- and middle-income countries.
Most patients with NMO do not have access to the test globally. Moreover, neuroimmunological disorders have
traditionally, but erroneously, been considered to be rare in Black patients, with costly diagnostic tests and even
more costly treatments, leading to limited expertise being built in lowest income African settings.
Recently, new advances in autoantibody detection using low-cost techniques have emerged, allowing
our team to detect the AQP4 antibody from small blood samples that are collected by the patient onto a filter
paper-based test and mailed to the processing laboratory. This method allows patients far from reference
laboratories to collect a dried blood sample and learn their diagnosis. These samples can be tested from warm
temperatures, stored at room temperature, and last months and still be processed successfully. When processed
at the Mayo Clinic Laboratories, dried blood spots have a high sensitivity and moderately high specificity for
AQP4 detection. The most immediate value for a point of care AQP4 test is in lowest income settings where
laboratory capacity is limited and antibody testing is not the current standard of care.
In this study, a collaborative team from Massachusetts General Hospital, Mayo Clinic Rochester, and the
Ignace Hospital in Guinea with three rural Guinean sites - Dubreka, Fouricariah, and Kindia - will focus on
capacity building for neuroimmunological diagnosis and management in the West African Republic of Guinea.
The team will test the point of care dried blood spot test in phenotypically-enriched cohorts at highest likelihood
of having AQP4 antibody positive NMO in Guinea and estimate point prevalence of NMO in these cohorts.
The well-defined subcohort of AQP4+ NMO patients will serve as a base for future clinical trials for the
Guinean investigators. The study team will leverage their deep and established expertise to elevate the status
of neuroimmunological disease expertise in West Africa. The team will also establish a workflow for testing at
the point of care for complex and devastating neuroimmunological diseases, a process that can be eventually
scaled for other point of care tests in remote, rural, and/or resource-limited settings.

Public health relevance
Neuromyelitis optica (NMO) is a rare, disabling, autoimmune disease that affects approximately 20,000 people in the United States and an estimated several million people globally, mostly women. This study aims to build capacity for the diagnosis and treatment of NMO and related neuroimmunological disorders in Guinea, a populous West African country without neuroimmunological expertise. The Guinean - U.S. investigators will test a novel, low-cost point-of-care aquaporin-4 antibody detection method to characterize the epidemiology of NMO in a new West African cohort and assess scale up of point-of-care CNS-focused autoantibody testing in low-income settings.